mRNA-LNPs for ARDS

ABSTRACT / PROJECT SUMMARY
Despite 50+ years of dissecting the pathways of acute respiratory distress syndrome (ARDS), there are
still no drugs which improve its mortality. From a pharmacology perspective, this lack of clinical trial success
falls into 2 major buckets: poor drug delivery to the alveoli and no platform technology to easily design a drug
for a given target protein. Here, we aim to solve these problems with a single nanotechnology. We began by
developing nano-scale drug carriers (nanocarriers) that can massively concentrate drugs in the alveoli,
~300-fold, after IV injection. These nanocarriers are lipid nanoparticles (LNPs) that are conjugated to targeting
moieties that either direct the LNPs to alveolar endothelial cells (via an anti-PECAM antibody on the LNP
surface), or to alveolar marginated leukocytes (via our recently developed NAP-tag). While we have for years
used these nanocarriers to deliver small molecule drugs, that class of cargo drugs had few molecules that
impacted ARDS-related pathways, and the drugs were difficult to load into LNPs. Therefore, here we will for
the first time deliver inside our alveolar-targeted LNPs a new class of drugs that can target virtually any
pathway: modified mRNA. Modified mRNA-LNPs drive the expression of encoded proteins for ~48 hours per
dose. In this proposal, we will combine our alveolar-targeting & mRNA technologies to treat two of the biggest
pathological processes of early-mid ARDS: alveolar capillary leak (Aim 1, targeting endothelial cells) and
leukocyte infiltration (Aim 2, targeting alveolar marginated leukocytes). For each of these 2 ARDS-related
disease processes, we will deliver mRNAs that encode either a secreted molecule (Ang1 or IL-10) or an
intracellular molecule (VE-cadherin or IkB), to compare how these different protein classes function with this
technology. Finally, we will test these in two ARDS-like mouse models of ARDS (Aims 1 & 2), and in ex vivo
human lungs (Aim 3). The platform technology developed here may directly produce an ARDS therapeutic,
and may also be extended later to probe ARDS pathophysiology, and treat other alveolar diseases.

Public health relevance
NARRATIVE Acute respiratory distress syndrome (ARDS) is an acute inflammation of the lungs, usually leading to 75,000 annual US deaths, but several times that since the start of COVID-19, which can cause ARDS. In ARDS, any of several inflammatory stimuli cause the lungs’ air sacs to develop leaky capillaries and infiltration by white blood cells. Here we will deliver to these air sacs mRNA encapsulated in lipid nanoparticles, which will drive the local expression of therapeutic proteins that will ameliorate both the capillary leak and deleterious white blood cells, potentially providing a new therapy for ARDS.